Neurophysiological Basis for Functional Connectivity Changes in Early Alzheimer’s Disease

Abstract
Early diagnosis and treatment of Alzheimer’s disease (AD) are critical for delaying the onset of clinical symptoms,
such as cognitive impairments and memory deficits. Early in AD, cognitively normal individuals who are positive
for amyloid-β, a predictive biomarker of AD, exhibit a transient increase in brain connectivity prior to a decline in
brain connectivity and cognition. This hyper-connectivity phase of AD suggests a prodromal pathology that may
be exploited as an early biomarker prior to the onset of clinical symptoms. Though these changes in brain
network connectivity have been well documented, little is known about the underlying neuropathology. I seek to
test whether localized increases in excitatory neuronal activity caused by amyloid-β drive the brain-wide hyper-
connectivity observed in early AD. I will use a multimodal imaging approach to determine the impact of amyloid-
β on neuronal and glutamate activity on the scale of the neuron (microscopic), regional neuronal circuit
(mesoscopic), and inter-regional network connectivity (macroscopic) in mouse models of AD. My proposal
comprises the following three aims: Aim 1: Determine the impact of acute exposure of amyloid-β on neuronal,
glutamate, and network activity in the normal cortex, Aim 2: Determine the impact of chronic, progressive
amyloid-β accumulation on neuronal, glutamate, and network activity in a young mouse model of AD, and Aim
3: Determine how total glutamate concentration changes, measured by translational magnetic resonance
spectroscopy, relate to synaptic glutamate activity changes with disease progression. Together, these
experiments could determine the neurophysiological underpinnings of the connectivity changes observed in early
AD. Data from this study could introduce novel treatment strategies for patients at risk of developing AD.
Furthermore, this work closely integrates my clinical interest in neuroimaging and neurology. In addition to
rigorous mentored research training, this proposal includes clinical experience and professional development
that will facilitate my growth into an independent physician-scientist.

Public health relevance
Narrative Individuals at risk of developing Alzheimer’s disease that are amyloid-β positive, but are still cognitively normal, exhibit a characteristic change in brain connectivity prior to the onset of clinical symptoms. However, the cause for these changes in brain connectivity are still unknown. In this proposal, I will use state-of-the-art neuroimaging techniques, such as in vivo two-photon microscopy, wide-field optical imaging, and magnetic resonance spectroscopy, to investigate changes in neuronal and glutamate activity and its impact on network connectivity response to amyloid-β exposure.